Development and Application of Organelle Chemotype Fingerprinting for the Functional Investigation of Organellar Chloride

SUMMARY/ABSTRACT
As one of the most abundant anions in the human body, chloride plays a crucial role in human health. Chloride
homeostasis is maintained inside the cell while the chloride level is varied based on the function of organelles.
Dysregulation of chloride homeostasis caused by the mutation of chloride channels results in various human
diseases such as cystic fibrosis (CFTR, >70,000 people worldwide), proteinuria and kidney stones (ClC-5, 39
million people in US), Osteoporosis (ClC-7, 10 million people in US, 43 million people in the risk group). Although
five FDA-approved chloride channel modulators have been reported, they only target plasma membrane chloride
channels due to the technical barrier. There is no FDA-approved or clinical trial drug that targets organellar
chloride channel. The field of chloride channel-targeted therapy is still under-studied (5 FDA-approved drugs, 2
clinical trial) compared to other channels such as calcium, potassium, and sodium.
The lack of understanding of the physiological role of organellar chloride and the well-characterized
chloride channel are the biggest roadblocks for the development of chloride channel-targeted therapy.
Therefore, suitable research tools with a high resolving ability to examine the organelle chloride in live
cells is a highly urgent need, which is essential to elucidate the physiological role of organellar chloride
and characterize the chloride channel. However, the current chloride measurement with one-dimensional
analysis only shows the average ion level. It cannot observe the chloride level change in a minor subset of
organelles triggered by the cellular pathway such as STING and autophagy. Furthermore, the typical
fluorescence measurement can only tell the variation of the average chloride level (increase, decrease, and no
significant change) in certain conditions. The current methods significantly hinder the identification of deactivated
cell pathways or protein based on the chloride level measurement.
The proposed research integrate organelle selective dual reporters, single organelle measurement, sub-
cellular imaging, and the three-dimensional analysis, to fingerprint the chemotype of organelles along with STING
pathway, autophagy, and mitochondrial respiration. Completion of the proposed study will find out the
physiological role of organellar chloride which shed light on the chloride channel-targeted therapy. The
development of the organelle chemotype fingerprinting technique will also provide tools to characterize chloride
channels, evaluate chloride channel modulators and identify the deactivated cell pathways or proteins.

Public health relevance
NARRATIVE Dysregulation of chloride homeostasis caused by chloride channel mutations results in a significant healthcare burden, such as kidney stones (39 million people in US), Osteoporosis (10 million people in US, 43 million people in the risk group). This project will develop “organelle chemotype fingerprinting” and employ this technique to elucidate the physiological role of organellar chloride, which is essential for developing new effective treatments.